The role of subsynaptic nanoscale architecture in inhibitory synaptic plasticity

PROJECT SUMMARY
Synaptic inhibition in the brain is critical for controlling neuronal circuit function, and its disruption underlies the
pathology of multiple neurological, psychiatric, and neurodevelopment disorders including epilepsy, anxiety,
autism, and schizophrenia. GABAergic inhibitory synapses mediate synaptic inhibition and regulate neuronal
excitability, cell firing, dendritic integration, and synaptic plasticity. Synaptic plasticity mechanisms drive changes
in synaptic strength in response to increased or decreased neuronal activity, which results in long-term
alterations responsible for learning, memory, and cognition. In one form of inhibitory synaptic plasticity, inhibitory
long-term potentiation (iLTP), GABAA receptors (GABAARs) accumulate at inhibitory synapses and are
stabilized, consequently increasing synaptic strength. However, the precise organization of newly recruited
synaptic GABAARs during iLTP and how this may contribute to increased synaptic strength is unknown.
Advances in super-resolution (SR) imaging techniques have revealed a common nanoscale architecture at
synapses in which neurotransmitter receptors, scaffolds, and adhesion molecules cluster into subsynaptic
domains (SSDs). Under basal conditions, SSDs of GABAARs require positioning close to sites of presynaptic
release for efficient synaptic transmission. This structured architecture is defined as the inhibitory nanocolumn.
It remains unclear if newly recruited GABAARs organize into SSDs within nanocolumns during iLTP, and whether
alterations to the inhibitory nanocolumn are required for synaptic potentiation. The overall goal of this proposal
is to determine how inhibitory synaptic nanostructure contributes to iLTP, and if the inhibitory synaptic
nanocolumn is a locus for synaptic plasticity. I hypothesize that precise positioning of GABAARs into SSDs
within the inhibitory nanocolumn opposite presynaptic release sites is an important mechanism involved
in functional iLTP. Using a range of super-resolution microscopy techniques, optogenetics, and
electrophysiology I will: identify changes in the size and density of GABAAR SSDs during iLTP, and importantly
their positioning within the inhibitory nanocolumn (Aim 1), determine whether mobile GABAARs are trapped in
nanoscale SSDs during iLTP (Aim 2), and investigate if positioning of GABAARs within the inhibitory nanocolumn
is required for synaptic potentiation (Aim 3). Together, this approach will determine a detailed understanding of
the precise nanoscale organization of GABAARs at inhibitory synapses during iLTP and provide crucial insight
into key mechanisms involved in inhibitory plasticity, overall synapse function, and neuronal activity.

Public health relevance
PROJECT NARRATIVE GABAergic inhibitory synapses mediate synaptic inhibition in the brain by regulating neuronal excitability, cell firing, dendritic integration, and synaptic plasticity – mechanisms which are critical for learning, memory, and cognition, and are disrupted in disease. The goal of this project is to investigate the fine details of synapse organization to understand how nanoscale subsynaptic architecture contributes to functional synaptic plasticity. This will begin to identify molecular interactions and structural mechanisms involved in the function and plasticity of inhibitory synapses and offer clues to how they are disrupted during disease.